Engineering an Oxygen-Carrying Perfusate for Normothermic Machine Lung Perfusion

PROJECT SUMMARY
Lung transplantation is the only definitive and successful therapy for end-stage lung disease. However, while the
waiting list of patients eligible for lung transplant grows, the number of suitable donor lungs falls far short of the
demand, and people are dying while waiting for acceptable lungs. To attempt to address this shortfall, there has
been an aggressive expansion of organ quality criteria for transplantation to meet this critical need. An evolving
strategy to meet the critical unmet demand for viable lungs suitable for transplantation is donation after circulatory
death (DCD) donation. Unfortunately, ischemia-reperfusion injury (IRI), which happens universally in
transplantation, is especially pronounced in these DCD allografts and highly variable. Therefore, resulting in the
use of marginal or extended criteria donor organs where there exists the increased potential for early allograft
dysfunction or failure after transplantation. Normothermic ex-vivo lung perfusion (EVLP) is a technology that
enables the assessment and, with sufficient metabolic support on the perfusion circuit, potential resuscitation of
DCD donor lungs significant metabolic debt. In current clinical practice, EVLP uses either an acellular perfusion
solution or perfusion solution containing red blood cells (RBCs), which are both unable to support the donor
organ for extended duration perfusions. There are no commercially available or viable blood alternatives that are
able to be used for EVLP. For RBC-based perfusates, there are limitations with respect to erythrocyte
degradation, hemolysis, and antigen exposure over time while on the EVLP circuit. We have demonstrated that
engineered hemoglobin-based oxygen carriers (HBOCs) can be tailored to mimic RBC oxygen delivery by mixing
tense and relaxed quaternary state polymerized hemoglobin molecules. These molecules are stable at
normothermia and can be the basis of an organ support solution or oxygen-carrying perfusate used to resuscitate
donor lungs prior to transplantation. An engineered and tailored oxygen affinity HBOC that can effectively deliver
oxygen over a broad range of physiologic conditions would be favorable, ensuring optimal lung viability. A novel,
innovative HBOC-based perfusate with a prescriptive O2 affinity tailored to effectively deliver O2 over a broad
range of physiologic conditions would favorably ensure lung viability, especially for lungs that have amassed
different metabolic debts. This supports the rationale that a tailored HBOC-based perfusate with tunable O2
affinity can effectively support DCD lungs by meeting the enormous and variable metabolic O2 debt incurred
during ischemia and can sustain organ viability through EVLP leading to successful transplantation. We will
engineer a tailored oxygen affinity HBOC perfusate mixtures and define their biocompatibility and stability (Aim
1) and we will demonstrate the ability of the novel, tunable HBOC formulation to resuscitate DCD lungs during
EVLP by meeting the metabolic demands of the lung to restore function and ensure successful transplantation
(Aim 2).

Public health relevance
PROJECT NARRATIVE Lung transplantation is limited by the availability of high-quality donor lungs, thus preventing access for patients to these lifesaving procedures. Donation after circulatory death (DCD) lung donors is an evolving strategy to bridge the gap, though at the expense of variable and significant ischemic injury. Normothermic ex-vivo lung perfusion is a platform that offers the ability to assess and potentially repair suboptimal lungs; however, it is limited by the inability to resuscitate these lungs adequately and ameliorate the incurred metabolic debts that prevents restoration of normal lung function facilitating a successful transplantation. Our studies will test a novel, tailored tense/relaxed quaternary state hemoglobin-based oxygen carrier mixture’s ability to resuscitate DCD donor lung ischemic injury through normothermic ex-vivo lung perfusion to enable subsequent successful transplantation.